Medical Imaging Informatics Training Grant

ABSTRACT (PROJECT DESCRIPTION)
With the “digital era of biomedicine” upon us, exciting opportunities arise to revolutionize how we perform scien-
tific research and deliver healthcare. Burgeoning areas like precision medicine foreshadow a transformation of
how we understand disease and its individually-tailored treatment. In this context, the importance of imaging
continues to grow, both as a driver of new knowledge and as a vital tool which uses these insights towards better
detection, diagnosis, and treatment for patients. But achieving the full promise of this future still requires over-
coming many barriers, and new imaging informaticians must be equipped with the cutting-edge skills that will
create and support the necessary computational advances and methods.
The UCLA Medical Imaging Informatics (MII) training program aims to be a leader in training this next generation
of imaging informaticians who will develop the needed computational approaches and applications that enable
this future. Bringing together leading experts from across our institution in imaging, engineering (computer and
data science, electrical, bioengineering), (bio)statistics, and medicine, MII envisions an environment fostering
interdisciplinary teaching and mentoring of students; and promoting innovative research throughout the spectrum
of imaging informatics. MII's training program involves a comprehensive 1-year core curriculum introducing foun-
dational principles of the discipline, forming a breadth of understanding while reinforcing the technical proficien-
cies needed by any imaging informatician. Students complete coursework covering topics presented from the
perspective of medical imaging and healthcare, including: information architectures; data and knowledge repre-
sentation; data mining; machine learning; biostatistics; and information retrieval. Cross-cutting topics (e.g., radi-
ogenomics, multimodal data integration and biomarker development) are presented throughout these courses.
In parallel to the core curriculum, students are immediately engaged in research, completing rotations with faculty
to gain an appreciation for contemporary imaging informatics projects. With this experience, PhD students sub-
sequently specialize via more advanced elective coursework customized to their particular research interests.
Students are challenged to propose, develop, and test new imaging informatics methods that will advance the
discipline, as well as ultimately change and affect healthcare. Importantly, both training and research are inter-
woven within a biomedical application domain and with appropriate PhD and MD mentorship to ensure compu-
tational/informatics, clinical, and real-world translational insights and guidance. Recognizing the evolving land-
scape of the biomedical workforce, our T32 includes a number of professional development activities, including
internships, providing practical (research) experiences in different settings. Through the experiences gained dur-
ing this T32 training program, MII students will become independent scientists, prepared to contribute to and
lead imaging informatics as it continues to grow.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The UCLA Medical Imaging Informatics (MII) training program aims to train and inspire a new generation of imaging informaticians who will lead the development of innovative approaches that inform and enable precision medicine. MII establishes a cross-campus, interdisciplinary environment to teach and mentor future scientists in cutting-edge computational and data science methods towards imaging; and creates novel, team science re- search opportunities in which graduate students work and learn from leading experts in the field. MII trainees are exposed to the breadth of contemporary imaging informatics research, and are ultimately prepared to be productive, independent scientists that will participate in shaping the discipline as biomedical research and healthcare evolve.